Examining Parent Presence and Participation in Caregiving in the NICU

Modified Project Summary/Abstract Section

While some barriers and facilitators to parent presence and participation (PPP) in the neonatal intensive care unit (NICU) have been identified, comprehensive descriptions of factors influencing PPP and changes in these factors over time are lacking. To improve outcomes for preterm infants and their parents, the factors influencing PPP must be identified. PPP is critical to improving clinical outcomes and neurodevelopment for preterm infants. The purpose of the proposed study is to comprehensively determine barriers and facilitators affecting PPP in the NICU and effects of PPP on infant outcomes. Using a non-experimental, longitudinal design, the following specific aims and subaims will be accomplished: (Aim 1) determine barriers and facilitators affecting PPP and changes in barriers and facilitators over time; (Subaim 1) predict barriers and facilitators of PPP for various groups of parents; (Aim 2) determine the effect of PPP on infant clinical outcomes and neurodevelopment; (Subaim 2) determine the mediation effect of parent-infant responsiveness on the relationship between PPP and infant clinical outcomes and neurodevelopment; (Aim 3) determine the moderation effect of PPP on the relationship between infant stress exposure and infant clinical outcomes and neurodevelopment. Parents with an infant born less than 32 weeks gestational age will be enrolled. Parents will complete surveys throughout their infant’s hospitalization to identify barriers and facilitators influencing PPP and to quantify their experiences of parent-staff engagement in the NICU. PPP will be quantified by parent-report, electronic health record documentation, and NICU visitation logs. Infant clinical outcomes, including length of NICU stay and achievement of oral feeding competence, will be measured throughout hospitalization and at discharge. Neurodevelopment will be assessed at 3-months corrected age using the Test of Infant Motor Performance and 12-months corrected age using the Bayley Scales of Infant and Toddler Development, 4th Edition. Parent-infant responsiveness at discharge and 3-months corrected age will be determined as will the moderating effect of PPP on infant stress exposure throughout hospitalization. The study focuses on modifiable factors that may affect PPP. The study will provide data to support the development of NICU interventions to promote PPP, thus improving outcomes for preterm infants and their families. This proposal addresses the research priority area of the NICHD’s Pregnancy and Perinatology Branch to advance the science of preterm birth and its consequences while incorporating the NICHD’s aspirational goal to enhance the healthy development of preterm infants.

Public health relevance
Modified Public Health Relevance Section The proposed project will determine the many influences on parent presence and participation in caregiving in the neonatal intensive care unit (NICU) and the importance of parent presence and participation for clinical and developmental outcomes of preterm infants. By studying these influences and how they change during an infant’s NICU hospitalization, specific interventions can be developed to improve infant outcomes. The study will also provide information to better understand reasons for differences in parent presence and participation across various populations.